Lineage Plasticity, due to Disruption of MnSOD Biology, drives resistance to Ionizing Radiation / Androgen Deprivation Therapy

SUMMARY - The overarching goal of this new R01 application is to investigate the dysregulation of mitochondrial
networks responsible for maintaining normal metabolism is an established hallmark of cancer. This disruption of
cellular metabolism, leads to the aberrant accumulation of reactive oxygen species (ROS), triggering
maladaptive signaling that is an emerging, novel mechanism leading to ionizing radiation (IR) resistance (IRR)
as well as enzalutamide (ENZ) resistance (ENZR). In this regard, recently identified a mitochondrial signaling
axis centered on manganese superoxide dismutase (MnSOD) which, when the acetylation (Ac) status of lysine
68 (K68-Ac) is altered, disrupts cellular metabolism, leading to aberrant ROS levels (Zhu, Nature Commun.,
2019). In addition, LNCaP cells expressing a MnSOD K68-Ac mimic mutant (MnSODK68Q) exhibited IRR/ENZR,
increased HIF2a, known to promote stemness properties, and two stem cell markers, Oct4 and SOX2. As such,
we seek to show that MnSOD-K68-Ac may drive IRR and/or ENZR, by altering MnSOD’s structural composition
and enzymatic activity, and in a broader context, tumor growth and survival via a cell stemness-like mechanism.
Finally, will GC4419 exposure, a chemical agent that acts as a MnSOD mimic, reverse the IRR/ENZR
phenotype? Thus, it is hypothesized that prostate tumor cells exposed to IRR and/or ENZR increase MnSOD-
K68-Ac, disrupting normal MnSOD biology at the cellular and mitochondrial level (i.e., aberrant ROS), which
initiates cellular reprogramming, via increased HIF2a, leading to lineage plasticity properties, a change in tumor
cell fate, and an IRR and/or ENZR tumor phenotype. It is also proposed that MnSOD-K68-Ac is a novel axis for
new therapeutic interventions in IRR and IRR/ENZR tumors. Finally, using GC4419, which that chemically
replaces MnSOD activity, we ask whether superoxide detoxification reverts/converts these IRR/ENZR prostate
tumor cells to a sensitive phenotype by restoring normal metabolism

Public health relevance
NARRATIVE - We recently identified a novel mitochondrial signaling axis centered on MnSOD-K68 which, when its normal acetylation status is altered, disrupts cellular metabolism, leading to aberrant ROS levels (Zhu et al, 2019). This data has been extended to show that LNCaP-MnSODK68Q cells exhibit increased HIF2a, shown to promote a stemness-like phenotype, and two stem cell biomarkers, SOX2, and Oct4, consistent with stemness properties. Thus, is the disruption of cell metabolism surrounding MnSOD-K68-Ac a potential mechanism for radiation resistance as well as enzalutamide resistance and potential molecular target for novel therapies?